Triglycerides as a Predictor of Newborn Subcutaneous and Liver Fat: Contributors to Fetal Fat Accretion in Obese Pregnancies

Project Summary/Abstract
Despite more than 40 RCT interventional trials in pregnant women at risk for delivering large-for-gestational age
(LGA) infants, there is currently no clearly effective treatment to reduce fetal overgrowth in overweight/obesity
(OW/OB), which account for ~70% of pregnancies. Maternal obesity remains the most common cause of LGA
infants and increased fat mass at birth, the latter a stronger harbinger for the development of childhood metabolic
disease. One in five preschoolers is already obese, and 40% already exhibit non-alcoholic fatty liver disease
(NAFLD), suggesting early life adipogenic influences. We have shown that newborns from mothers with obesity
and gestational diabetes are born with 68% more liver fat than those from normal-weight (NW) mothers, and
earlier maternal TG, before subcutaneous fat stores have developed, predicted newborn liver fat. Non-human
primate data support that liver fat at birth predicts later NAFLD. Our data show that under controlled conditions,
OB mothers have 30-40% higher fasting and postprandial triglycerides (FTG, PPTG) throughout pregnancy.
Moreover, FTG and PPTG are more predictive of newborn fat than glucose, BMI or fat mass, insulin resistance,
or weight gain. Although maternal PPTG independently predicted 50% of the variance in newborn fat early (14
wks), by later pregnancy (28 wks) this effect was augmented by glucose. This suggests that rising glucose later
in pregnancy stimulates fetal insulin (cord C-peptide), and when combined with excess TG availability, augments
newborn fat storage. Although some data support TG in fetal overgrowth, TG are not measured as part of routine
obstetric practice. In part, this is due to prior unavailability of a portable TG meter (similar to a glucometer) that
allows repeated testing, which we have now successfully piloted. In this prospective cohort trial in OW/OB
pregnancies we will, for the first time, obtain repeated measures of TG and glucose (by CGM) to define: 1) at
what level of TG the risk of fetal overgrowth increases, and if this occurs independent of or in synergy with
glucose; 2) when in pregnancy the TG exposure is most important, 3) if fasting vs postprandial TG results in
greater newborn subcutaneous fat (Specific Aim 1; by air-displacement plethysmography) or in newborn liver
fat (Specific Aim 2; by magnetic resonance spectroscopy), independent of other risk factors and accounting for
sex differences. In our Exploratory Aim, we will interrogate mechanisms by which placental lipid transport
pathways may facilitate fetal fatty acid (FA) delivery, the lipidomic signatures of maternal and cord blood which
correspond with increased fetal fat accretion, and the adipogenic potential of umbilical mesenchymal stem cells.
Completion of this community-based trial may provide compelling evidence to support a paradigm shift in
obstetric practice that endorses meter TG monitoring, similar to glucometers in gestational diabetes, for mothers
at risk for fetal overgrowth. Clinically impactful, these data may inform a future interventional trial in which TG
are targeted with safe TG-lowering agents (i.e., high dose omega 3-FA supplements) to prevent excess newborn
subcutaneous and liver fat, with the goal of decreasing childhood risk for obesity, NAFLD, and metabolic disease.

Public health relevance
Project Narrative Infants born to mothers who are overweight or obese during pregnancy (70% of pregnant women) are more likely to have increased fat mass at birth, an important risk factor for childhood obesity which can be accompanied by childhood non-alcoholic liver disease (NAFLD). There are no effective interventions in obese pregnancies to significantly reduce fetal overgrowth, but we have shown that maternal triglyceride levels are much higher in obesity and triglycerides are stronger predictors than glucose for newborn fat mass and liver fat storage. In this community study, we will determine the role and timing of maternal fasting and post-meal triglycerides on newborn fat mass and liver fat and mechanistically examine placental transport and early fat cell development which may identify a novel strategy to prevent fetal overgrowth and childhood metabolic disease.